Neurofibromatosis and Schwannomatosis Genes Variant Curation Expert Panel (VCEP)

ABSTRACT
The goal of the Neurofibromatosis (NF) and Schwannomatosis (SWN) Genes Variant Curation Expert
Panel (VCEP) is to develop, apply, and disseminate variant curation guidelines for genes associated with
neurofibromatosis type 1 (NF1), Legius syndrome (LS), and schwannomatosis (SWN), including NF2-related
schwannomatosis (NF2-SWN, formerly known as neurofibromatosis 2) and non-NF2-related schwannomatosis
(non-NF2-SWN). NIH has prioritized identifying genetic variants associated with neurological disease and
inherited susceptibility to cancer and determining their clinical significance for diagnosis and treatment.
NF1 is caused by pathogenic variants (PV) in NF1 whereas LS is caused by PV in SPRED1. SWN is caused
by PV in NF2, SMARCB1 and LZTR1. Patients affected by these neurogenetic tumor suppressor syndromes
are commonly managed together in specialized clinics that provide comprehensive care. Historically, these
syndromes have been diagnosed clinically, but new international guidelines recommend the use of genetic
testing to assist diagnosis. In cancer patients, multigene panels may identify germline variants in NF1, NF2,
SPRED1, SMARCB1, and LZTR1 that are pathogenic, likely pathogenic, or of uncertain significance (VUS) in
persons who may not exhibit clinical features of NF or SWN. Improved variant classification will foster earlier
and more accurate diagnosis and improve treatment for these conditions. A key goal of the VCEP, is to
standardize intepretation of variants in these cancer genes and to reduce the number of VUS.
Currently, there are no gene-specific guidelines for curation of variants associated with NF1, LS, and SWN and
no comprehensive database for these variants. In late 2021, 43 international experts from 14 countries
launched an NF/SWN VCEP. ClinGen has provided Step 2 approval for the VCEP to develop gene-specific
rules for NF1. Funding will allow the VCEP to test proposed rules for NF1 and to create variant curation rules
for NF2 (one of the 73 ACMG Secondary Findings Genes), SMARCB1, LZTR1, and SPRED1.
Our approach is to focus on standardization, not innovation. The Specific Aims of the propsal are to:
1. Develop gene-specific guidelines for curation of genes associated with NF1, LS, and SWN with the
guidance of rigorous, established, and standardized ClinGen processes and procedures.
2. Curate a wide array of simple and challenging variants to ensure that the guidelines developed are able
to classify known pathogenic and benign variants while reducing the number of VUS.
3. Reclassify variants curently in the literature and public databases (LOVD and ClinVar) and deposit them
in ClinVar, making them available to the international community and testing laboratories.
4. Disseminate these guidelines by publishing them in peer-reviewed journals, thereby making them freely
available for members of the NF community, academic laboratires, and commercial laboratories.
This project will standardize curation among academic and commercial labs, will improve the diagnosis and
treatment of patients, and will increase the number of curated variants in ClinVar.
page 1

Public health relevance
NARRATIVE The goal of the Neurofibromatosis (NF) and Schwannomatosis (SWN) Genes Variant Curation Expert Panel (VCEP) is to develop, apply, and disseminate disease-specific curation guidelines for genes associated with neurofibromatosis type 1 (NF1), Legius syndrome (LS), and schwannomatosis (SWN), including NF2-related schwannomatosis (NF2-SWN, formerly known as neurofibromatosis type 2) and non-NF2-related schwannomatosis (non-NF2-SWN). The team will publish a series of manuscripts describing the ClinGen- endorsed specific guidelines for interpreting germline variants in NF1, NF2, SMARCB1, LZTR1, and SPRED1. This information will standardize the assignment of pathogenicity across academic and commercial labs, will improve the diagnosis clinical management of patients by clarifying the interpretation of both intronic and missense variants, and will increase the number of curated variants deposited in ClinVar. page 1